Epstein Barr Virus Latency

DESCRIPTION (provided by applicant): Epstein-Barr virus is a herpesvirus that infects >90% of the human population. It has two distinguishing characteristics. First it is able to maintain a life long persistent infection in healthy hosts and second it is associated with several human lymphomas and carcinomas. This proposal will address central issues related to these two properties. Persistence: EBV establishes a persistent latent infection in memory B cells. Much is known about how it does this but less is known about how the latently infected cell produces infectious virus to spread to other hosts. Our preliminary data indicate that the signal for viral replication is the terminal differentiation of the latently infected cell into a plasma cell. We will use standard molecular biological tools to identify the role of plasma cell specific transcription factors in activating the EBV lytic cycle. Since plasma cells replicate the virus only when they are fully differentiated it is likely that they release infectious virus when they migrate to the bone marrow. This would result in early B cell progenitors becoming infected. These cells could also provide a site of life time persistent infection. Therefore, the second aim of this study will be to test the role of the bone marrow as a second site of viral persistence. This will be achieved by fractionating the bone marrow into the known subsets of B cells and testing for the presence of the virus by quantitative DNA and RT PCR techniques that we have developed. Neoplasia: One of the commonest tumors associated with EBV is nasopharyngeal carcinoma. There remains little known about the molecular basis of this tumor and its association with EBV. We will use Affymetrix chip technology to provide a molecular genetic definition of NPC that distinguishes Type II and Type III (poorly and undifferentiated NPC) and tumors negative and positive for the EBV encoded oncogene LMP1. Our preliminary data demonstrates the feasibility of this approach. This analysis will identify candidate marker genes for the different types of NPC and test their roles in in vitro and in vivo models. Specifically this approach will be used to identify genes and signaling pathways activated by LMP1. This will provide a molecular basis for explaining the role of LMP1 in NPC.